In vivo epigenetic reprogramming of retinal ganglion cells in aging mice with glaucoma

Glaucoma is a major cause of irreversible blindness worldwide that specifically targets retinal ganglion cells
(RGCs) and their axons, causing loss of function, and ultimately cell death. Currently approved therapies for
glaucoma patients lower intraocular pressure (IOP), which can slow but not stop disease progression.
Importantly, these treatments only indirectly affect the retina and do not provide any direct effect on RGC
survival. Therefore, an important unmet need is to identify new therapeutic targets for glaucoma patients that
protect and/or rejuvenate RGCs. Although aging is a highly significant risk factor for glaucoma, very little is
known about how and why aging causes patients to become more susceptible. Recent studies by colleagues
demonstrated that RGC susceptibility to IOP-induced stress increases with age and coincides with histone and
chromatin changes, indicating an epigenetic mediated mechanism. Moreover, IOP-induced-injury accelerated
RGC aging, directly connecting injury with the aging process. Thus, there are at least two important
components of glaucoma (i) stress induced RGC injury by elevated IOP, and (ii) the negative effects of aging
that increases RGC susceptibility to stress. Therefore, the only way to completely understand the pathobiology
of glaucoma is to use model systems that include the effects of both aging, and stress. Another pressing
reason to understand how aging contributes to glaucoma is that we, along with our collaborators, showed that
aging can be reversed. We were the first to reverse in vivo physiological aging of any tissues within the
mouse. This was achieved using a gene therapy that triggered “transient epigenetic reprogramming” of
RGCs via AAV2 delivery of three of the four Yamanaka factors OSK (Oct4, Sox2, Klf4) which rejuvenated
RGCs and restored visual function lost due to aging. The experiments described herein will extend our
previous research to (i) investigate the combined effects of aging and elevated IOP on the development of
glaucoma and the RGC transcriptome, (ii) identify the age- and glaucoma-specific transcriptomic changes, and
(iii) determine how these transcriptomic changes are altered by OSK epigenetic reprogramming. We
hypothesize the rejuvenating effects of OSK mediated epigenetic reprogramming in aging mice with glaucoma
are due to the reversal of both age- and IOP-induced changes in the RGC transcriptome, which are
epigenetically dependent upon the Tet 1,2 mediated CpG methyl transferase enzymes. Three specific aims are
proposed: (Aim 1) demonstrate elevated IOP induced glaucoma in aging mice is more severe and in vivo
transient AAV2-OSK mediated epigenetic reprogramming restores visual function, rejuvenates RGCs, and
prevents loss of RGCs and axons, (Aim 2) determine the age-associated changes that occur in the RGC
transcriptome using scRNAseq and how AAV2-OSK epigenetic reprogramming reverses these changes and
restores function, and (Aim 3) determine the elevated IOP induced changes in the RGC transcriptome of
aging mice and how AAV2-OSK epigenetic reprogramming reverses these changes and restores function.

Public health relevance
Project Narrative Glaucoma is a major cause of irreversible blindness worldwide that specifically targets a single cell type in the retina called retinal ganglion cells and is associated with, but not directly caused by, elevation of intraocular pressure. Although it is known that aging is one of the biggest risk factors for glaucoma, little is known about why or how aging increases the risk of developing this disease. This study will determine how aging changes retinal ganglion cells to make them more susceptible to glaucoma and whether a novel type of gene therapy that induces “transient epigenetic reprogramming” is capable of treating glaucoma by reversing the age of retinal ganglion cells and making them younger, thus targeting aging, one of the root causes of this disease, as opposed to treating the symptoms.